Private Equity Acquisitions in Primary Care: Effects on the Medicare Program

Project Summary
Private equity acquisitions have accelerated in primary care, comprising thousands of physicians covering
hundreds of thousands of lives across the U.S. Despite this growth, the effects of these acquisitions on clinical
and economic outcomes remains unknown. Limited evidence in other parts of the delivery system, including
nursing homes, hospitals, and procedural specialists, shows that PE acquisition is associated with higher
prices and spending, as well as potential negative effects on quality. How PE ownership of primary care
practices affects the health and health care of Medicare beneficiaries is a fundamental question, as Medicare
covers primary care for nearly 60 million beneficiaries with chronic diseases - an AHRQ priority population.
This proposal focuses on the specific mechanisms by which PE firms may affect provider behavior under
different financial incentives in Traditional Medicare (TM) and Medicare Advantage (MA), and estimates effects
on quality of care and patient outcomes. We propose to link primary care acquisition data to TM claims and MA
encounter data from 2016-2024; using a quasi-experimental event study framework, we compare changes
among beneficiaries in PE-acquired primary care practices with matched control beneficiaries of non-PE
acquired primary care practices. In TM, we hypothesize that PE increases the utilization of services, and
specifically low-value services like unnecessary or wasteful tests, imaging, or procedures. In MA, increased
utilization can be counterproductive under a capitated budget, and we thus hypothesize that PE maximizes
revenue through differentially more intensive coding of clinical diagnoses to garner higher risk-adjusted
payments from the federal government. Our aims are to: 1) examine changes in provider behavior associated
with PE acquisition of primary care practices, including utilization of low-value services and diagnostic coding
intensity; 2) estimate changes in quality of care and patient outcomes; and 3) understand treatment effect
heterogeneity, including by patient racial/ethnic and geographic composition, as well as by provider and
practice characteristics. We apply a number of innovations, including the development of a novel dataset of PE
acquisitions in primary care, which will be made publicly available for future use. In order to better approach
causal inference, we also apply statistical innovations, including identification strategies in difference-in-
differences analyses, risk set matching and cardinality matching to match a treated individual to comparable
controls, and application of minimum variance balance weights. Findings will provide novel, timely, and
comprehensive quantitative assessments of changes in key clinical and economic outcomes associated with a
growing trend of PE ownership in primary care, and will be highly policy relevant as federal and state
governments consider ways to preserve and support access to high-value primary care.
1

Public health relevance
Project Narrative As acquisitions of primary care practices by private equity (PE) firms accelerate nationwide, this proposal focuses on the specific mechanisms by which PE firms may alter provider behavior under different financial incentives in Traditional Medicare and Medicare Advantage, which together cover primary care services for nearly 60 million Americans. We apply newer statistical methods to estimate PE's effects on quality of care and patient outcomes, as well as to assess heterogeneous treatment effects across different patient populations and impacts on health care equity. Findings will provide novel, timely, and comprehensive quantitative assessments of this growing trend of PE practice ownership, helping to inform ongoing state and federal policy efforts to support access to high-value primary care.